Bio Atomic Force Microscope

Project Summary
The instrument requested is an Asylum Research MFP-3D-Bio Atomic Force Microscope (AFM) from Oxford
Instruments mounted on a new Olympus IX73 inverted fluorescent microscope into one integrated system to
be located at Michigan Tech. An AFM is extremely versatile equipment that can measure nanoscale
topography, force between different tip chemistry and a sample, and mechanical properties with
nanoindentation. When combined with a microscope, cells and other micron-size objects can be visualized and
precise locations on cells can be probed with AFM and simultaneously capture either brightfield or
fluorescence microscopic images, thus the integrated system is called a Bio-AFM. Michigan Tech has the
expertise and facilities for training, data analysis, and complex analysis using the AFM from researchers and
technical staff. The Bio-AFM will provide three main advantages that are not available in the AFM equipment
currently at Michigan Tech: with the addition of a microscope and heated stage (i.e. petri dish heater with
environmental control), cells can now be used in conjunction with the measurement capabilities of the AFM;
the BSL-2 cleaning protocols that will be implemented around the Bio-AFM and the isolation in one room will
allow a larger range of biomolecules to be studied; and the z-extender will allow for pulling experiments of
proteins and polymers for expanded experimental capability. These additional accessories are what propel this
instrument to be of extreme use to NIH funded researchers on campus. The researchers will explore how cells
move and cancer metastasizes on different biomaterials, how metabolism of different sugars and metabolites
can affect cell morphology and elasticity, and how viruses change structure and have different chemical
properties during inactivation and manufacturing. The large, proposed user base demonstrates the excitement
this instrument has garnered at Michigan Tech and another regional university. We want Michigan Tech to
become a regional hub for instrumentation, facilities, and expertise in biomedical research. By bringing
together these things in the rural upper mid-west, we can leverage our unique location, diverse portfolio of
research, and our diverse student body, many who come from lower socio-economic backgrounds, to provide
a vibrant location for biomedical training. This Bio-AFM at Michigan Tech will help NIH to increase the diversity
of trainees, as well as diversity in thought in ways to apply the instrument to biomedical research.

Public health relevance
Project Narrative This project will purchase, install, and train user to use a new Bio-Atomic Force Microscope (Bio-AFM) from Oxford Instruments in conjunction with a new Olympus inverted microscope as an integrated instrument. The Bio-AFM will provide unprecedented access to study cells and biomaterials for nanoscale topography, force between different tip chemistry and a sample, and mechanical properties with nanoindentation. This Bio-AFM at Michigan Tech will help NIH to increase the diversity of trainees, as well as diversity in thought in ways to apply the instrument to biomedical research.